Developing modulators of the sperm-specific potassium channel SLO3 for contraception

PROJECT SUMMARY
The high (~45%) rate of unintended pregnancies in the US is largely due to incorrect or inconsistent use of
contraceptives, indicating that available contraceptives are failing to meet women's needs. An ideal female
contraceptive will: 1) be highly effective at preventing pregnancy, 2) not act as an abortifacient, 3) have no
negative side effects, and 4) not depend on hormones. We propose that the potassium (K+) channel SLO3 is an
ideal target for the development of a contraceptive that meets these criteria. This idea is founded on several
unique aspects of SLO3 channels. First, SLO3 is absolutely required for sperm capacitation; mice lacking SLO3
are healthy but infertile because their sperm fail to undergo processes essential to their ability to fuse with an
oocyte, hyperactivation (a vigorous type of motility essential to fertilization) and the acrosome reaction (release
of the acrosome content). Second, these processes occur in the female genital tract, so a drug targeting SLO3
will be an effective, non-hormonal, non-abortifacient, female contraceptive. Finally, SLO3 channels are only
expressed in sperm cells in humans and other mammals, so a contraceptive targeting this channel will affect no
other cell in a woman's body. Our objective here is to develop inhibitors of SLO3 that will act as non-hormonal
and reversible female contraceptives. To achieve our objective, in the R61 Phase of the grant we will: 1) employ
high-throughput screening (HTS) to identify potent and specific small-molecule inhibitors of SLO3 channels, and
2) perform patch clamp electrophysiology to test potency and selectivity of SLO3 inhibitors identified in aim 1. In
the R33 Phase we will: 3) optimize SLO3 modulators via medicinal chemistry and 4) determine the effects of
SLO3 inhibitors on human sperm K+ currents and human sperm function.
The research proposed here will identify lead molecules that can be developed into an innovative class of female
non-hormonal contraceptives that act by targeting sperm capacitation. The information obtained from these
studies will also contribute new knowledge to the field, specifically a deeper understanding of the role of ion
channels in sperm physiology.

Public health relevance
PROJECT NARRATIVE This proposal contributes to improving reproductive health by focusing on preventing unintended pregnancies. Currently, all reversible female contraceptives have side effects that prevent their wide acceptance. This project will address this gap by identifying lead molecules that can be developed into an innovative class of female contraceptives that act by targeting sperm function.